GENOTYPIC-PHENOTYPIC CORRELATIONS IN HEREDITARY MOVEMENT DISORDERS

1) We found that familial cardiac and skeletal myopathy characterized by accumulation of desmin deposits in muscle cells is associated with mutations in the desmin gene. A heterozygous A337P mutation was identified in a family with late onset slowly progressive skeletal myopathy with mild cardiac involvement. Compound heterozygosity for two other mutations, A360P and N393I, was detected in a second family characterized by childhood onset and aggressive course of cardiac and skeletal myopathy. SW13-minus cells expressing each of these mutations suffer complete destruction of desmin network and accumulation of granular desmin-positive deposits. In-vitro experiments confirmed pathogenic potentials of the mutations we have identified in our patients. 2) Two separate disorders, distal spinal muscular atrophy type V (dSMA-V) and Charcot-Marie-Tooth disease type 2D (CMT2D) were diagnosed in a single large kindred. Multipoint lod score of 6.07 suggested that the gene for both syndromes is located between markers D7S526 and D7S474. A conserved disease-associ- ated haplotype was established in affected individuals suffering from either disorder. Based on informative recombination events, the disease locus was placed within a 3 cM interval between markers D7S2496 and D7S1514 within the 7p15 band. Data obtained from this study suggest that a single gene is responsible for both syndromes, dSMA-V and CMT2D, increase the resolution of the candidate locus and facilitate the search for the gene.